Identification of Clinically Important Microbes by Genomic and Proteomic Methods

Historically, the detection and identification of bacteria, mycobacteria, yeasts, and molds have relied primarily on their morphologic and phenotypic properties. This approach is imprecise and slow for many clinically significant microbes. We have explored alternative methods, such as targeted sequencing and mass spectrometry, for the detection and identification of selected organisms. Studies in the current fiscal year have focused on alternative identification methods, specifically MALDI-TOF (matrix-assisted laser desorption-ionization time of flight mass spectrometry) for the identification of Nocardia, mycobacteria, and molds and rapid genomic assays for identification, typing and detection of antibiotic resistance in M. abscessus group. MALDI-TOF MS provides a reproducible spectral pattern based on the mass/charge (m/z) ratio of ionized proteins. Preparation of samples is rapid and inexpensive. Well-characterized reference strains of mycobacteria, Nocardia and molds allowed us to build a NIH database that was then challenged with clinical isolates. Following a demonstration of excellent performance, MALDI-TOF MS has become the method of choice of the NIH Microbiology Service for identification of both rapid and slowly growing mycobacteria as well as filamentous molds. This approach has been recently validated for the identification of Nocardia at the NIH and more recently also at two other academic centers. A multi center evaluations of the performance of the NIH mold database is ongoing. Finally, we are exploring the use of proteomics and in particular Maldi-Tof MS for direct detection of microbial antigens in clinical samples and our project was granted a Bench to Bedside (BtB) award. Our findings support the validity of this approach for detection of circulating antigens of Mycobacterium tuberculosis and Mycobacterium avium complex and is being currently evaluated for other species of mycobacteria.